Biobank Core

Project summary- Biobank Core
The overall goal of the BioBank core is to help investigators process and store biological samples
from patients with ocular disorders. The processing of biological samples from patients with ocular
disorders is an integral part of many research programs at Massachusetts Eye and Ear (MEE). By
providing a central facility for sample processing, the BioBank resources reduce duplicated efforts
among investigators. Centralized storage and tracking using state-of-the-art programs ensures
sample maintenance and protection and minimizes sample loss and mix-up. Additionally, providing
assistance with sample collection helps young investigators and clinical scientists who may not yet
have funding to collect useful patient samples. The collection of patient samples and/or DNA can be
important preliminary data for funding applications for genetic or other analyses. The availability of
patient sample resources also supports new investigations and collaborations, especially between
basic and clinical scientists forming another bridge between basic and clinical research at MEE.